Diabetes and Metabolism

Project Abstract
In 1988 the Mayo Clinic training programs in Endocrinology (DK07147 funded in 1968) and Diabetes and
Metabolism (DK07352 funded in 1979) were merged to create this Training Program in Diabetes and
Metabolism (DK07352). Our Program supports postdoctoral research training in Endocrinology, Diabetes and
Metabolism for individuals with MD or PhD degrees. Our goal is to prepare trainees for academic careers with
the ability to contribute as an independent investigator. The Program supports up to three years of laboratory
research training. The faculty consist of 22 investigators funded with NIH R01 grants and/or other funds, 5 of
whom are junior faculty members in the process of developing independent programs and mentoring skills. We
have 49 adjunct faculty in both basic science and clinical departments. The Program is designed to provide
trainees with: (i) intense, in-depth education regarding all components of the scientific method, (ii) a specific
project to gain a focused approach to scientific investigation, (iii) experience with state-of-the-art analytical
tools and methodologies, (iv) grant writing abilities, and (v) the skill sets needed to become independent
biomedical research scientists. We provide formal didactic course work (including classes on grant writing and
participation in mock study sections), the opportunity to attend intra- and extra-mural seminars, conferences
and scientific presentations related to their area of study. This is in the context of a focused research
experience in the laboratories of established investigators. The Program is administered by the Steering
Committee and chaired by the Program Director, with advice from an External Advisory Committee. The
Steering Committee is responsible for interviewing and selecting trainees, as well as assuring they have an
appropriate laboratory assignment and didactic curricula. They review the trainees' initial project, and assist
with the annual review of the trainees' progress.
We are committed to maintaining the Program's focused approach to well-defined training goals for each
laboratory-based trainee combined with sufficient dedicated research time to optimize the educational
experience. Our full facutly are very successful in obtaining extramural funding as we would expect of
independent investigators that serve as primary faculty. We are proud of the productive training record of the
training program, which has been enhanced by our enthusiastic and knowledgeable junior training faculty,
together with help from adjunct faculty whose primary areas of basic science and/or clinical investigation are
intimately tied to those of metabolism, diabetes and endocrinology. The breadth of the faculty's research
programs is notable; ranging from molecular endocrinology to clinical research. Due to the program's
popularity and success, and the large amount of research funds awarded to our highly qualified faculty, we
propose to continue our program at the current level of 6 fellowship slots.

Public health relevance
This application is for renewal of a Training Program in Diabetes and Metabolism that has been funded for the last 40 years. The Program provides postdoctoral research training for MD's, PhD's, or MD/PhD's in Diabetes and Metabolism for 6 individuals for a maximum of three years. Trainees will work in the laboratores of 22 investigators in preparation for academic careers as independent investigators.